Engineered extracellular vesicles derived from mesenchymal stem cells for the treatment of type 1 diabetes

Abstract
Type 1 diabetes (T1D) is an autoimmune disease wherein a loss in immune tolerance leads to the
initiation and progressive destruction of insulin-producing β cells. Numerous immune interventions have been
reported to delay β-cell loss, but a few clinical trials have demonstrated safety and efficacy. Arguably, Fc
receptor–nonbinding anti-CD3 monoclonal antibodies (anti-CD3 mAb) have been the most successful clinical
immunotherapy for T1D, showing promising clinical outcomes in patients with new onset T1D as well as high-
risk, nondiabetic relatives of T1D patients. However, a significant number of patients still did not respond
positively to anti-CD3 therapy and the duration of response is limited. Hence, there is a critical need to develop
novel therapeutic interventions to induce immune tolerance for the treatment of T1D. Programmed cell death
protein 1 (PD-1): PD-Ligand 1 (PD-L1) axis plays important roles in immune tolerance. NOD mice lacking PD-
L1 or PD-1 develop accelerated T1D and PD-1/PD-L1 expression is low in immune cells of both NOD mice and
T1D patients. Genetically engineering approaches to overexpress PD-L1 or PD-1 in immune cells have shown
to promote immune tolerance in T1D. However, there are still challenges in clinical applications of viral
engineered cells such as toxicity, genotoxicity, low engraftment of gene-edited cells. PD-1/PD-L1 axis also plays
a critical role in anti-CD3-mediated tolerance in T1D. Anti-CD3 therapy induces immune tolerance in overt T1D
in TGFβ-dependent mechanisms, however CD3 antibody-induced remission of T1D in NOD mice is fully
reversed by PD-1/PD-L1 blockade, suggesting that the PD-1/PD-L1 axis may also play a critical role in the
response of T1D patients to anti-CD3 immunotherapy. Thus, combining anti-CD3 mAb with TGFb1/PD-L
treatment may more synergistically restore immune tolerance in T1D; however, this has not yet been tested.
Therefore, the overall goal of the proposed study is to develop a viral engineering- and cell-free strategy to deliver
TGFβ1 and PD-L1 for inducing immune tolerance in T1D using extracellular vesicles (EVs) produced from
mesenchymal stem cells (MSCs). Our central hypothesis that MSC-derived EVs (MSC-EVs) engineered to
deliver TGFb1 and PD-L1 effectively induce immune tolerance in T1D and synergistically enhance anti-CD3-
mediated tolerance in T1D. Aim 1 is to define the mechanisms by which EVs carrying TGFb1 and PD-L1
suppress auto-reactive T cells. Aim 2 is to demonstrate the therapeutic effect of the engineered EVs in
prevention and reversal of T1D onset. Aim 3 is to examine the synergistic effect of the engineered EVs on anti-
CD3-mediated tolerance. The proposed project will provide EV-based therapy to induce immune tolerance and
help improve the efficacy and safety of anti-CD3 therapy in T1D. The significant preclinical data of the
engineered EVs in prevention and reversal of new-onset T1D will facilitate the development of robust and ready-
to-use MSC-EV therapeutics for T1D and other autoimmune diseases.

Public health relevance
Narrative Type 1 diabetes (T1D) is an autoimmune disease wherein a loss in immune tolerance leads to the progressive destruction of insulin-producing β cells, resulting in hyperglycemia and complications, but there is no cure for T1D. This proposal will investigate whether extracellular vesicles (EVs) produced by mesenchymal stem cells (MSCs) can induce immune tolerance, thereby ablating T1D-associated autoimmunity. The success of the proposed research will provide essential insights and valuable information for the rational design of EV- based interventions, ultimately leading to the development of novel, safe and clinically feasible cell-free therapy using MSC-derived EVs for T1D treatment.